The Role of Rheology and Transfusion on Microvascular Thrombosis in Sepsis

PROJECT SUMMARY/ABSTRACT
Sepsis affects nearly 50 million people worldwide each year and the mortality rate for patients admitted to the
intensive care unit (ICU) is between 20 and 30%. There is clinical need to understand this pathophysiology
which causes the organ failure and high rates of mortality in order to identify efficacious therapies. Decreased
microvascular perfusion and endothelial cell (EC) injury are known to be involved but the mechanisms
underlying them remain incompletely studied. EC injury in sepsis promotes a change to a pro-adhesive, pro-
thrombotic cell phenotype. Disturbances in microvascular rheology – the biophysical behavior of blood in the
smallest blood vessels as a result of red blood cell (RBC) aggregation and cell membrane deformability – have
been observed in patients with sepsis and contribute to reduced microvascular perfusion. Given the EC layer’s
mechanosensitive nature, the central hypothesis for this project states that changes in microvascular
rheology contribute to EC injury and are predictive of organ failure and mortality in patients with
sepsis. It is further proposed that through manipulation of patient rheology with RBC and plasma transfusion
we can augment this injury specifically to improve perfusion and reduce microvascular thrombosis. Using state
of the art microfluidics assays, this project will characterize how RBC aggregation and membrane deformability
affect EC expression of adhesion molecules and anti-coagulant factors using whole blood samples from
patients admitted to the ICU with sepsis (Aim 1.1). Clinical correlates of these experiments will be defined
through unbiased and supervised class analysis modeling using machine learning (ML) approaches to
determine the impact of rheology (Aim 1.2). An array of RBC and plasma transfusions will be performed to
assess the impact on measured rheologic parameters of patient samples and identify optimal transfusion
strategies to reduce the risk of micro-thrombosis formation (Aim 2). The expected finding from this project is
that blood from patients showing increased RBC aggregation and reduced RBC membrane deformability will
induce greater levels of EC injury and class analysis will identify a group of patients with a hyperinflammatory
and disturbed rheology endotype as a high risk group for severe organ injury and mortality. It is also expected
that the patient samples which improve in rheologic measurements with transfusion will also demonstrate
reduced microvascular thrombosis burden. The long term goal of this project is to facilitate the principal
investigator’s career towards becoming an independently funded physician scientist studying microvascular
physiology and thrombosis in pulmonary and critical illness. The short term goal is for the principal
investigator to gain expertise in EC transcriptomics, transfusion and coagulation medicine, and ML approaches
to answer complex clinical questions.

Public health relevance
PROJECT NARRATIVE Sepsis affects nearly 50 million people worldwide each year with mortality rates estimated between 20% and 30%. While the syndrome is defined by a dysregulated inflammatory response to a microbial infection, the exact mechanisms which lead to the organ failure associated morbidity and mortality remain incompletely characterized. The proposed work will test the hypothesis that rheologic disturbances in the microvasculature, driven by increased in red blood cell aggregation and decreased cell membrane deformability, contribute to endothelial injury, micro-thrombisis and subsequent organ failure and that these changes can be influenced by blood product transfusion.